DMS/NIGMS 2: Advanced Statistical Methods for Spatially Resolved Transcriptomics Studies

Project Summary
The recent emergence of various spatially resolved transcriptomic technologies have enabled the study of
spatial transcriptomic landscape across a tissue section or within single cells, catalyzing new discoveries in
many areas of biology. Despite the fast development of spatial transcriptomic technologies, however, statistical
methods for analyzing spatial transcriptomic data are vastly underdeveloped. In the funded parent award, we
proposed to develop a suite of novel statistical methods and computational tools (1) to model the spatial
correlation structure in a computational effective way to rapidly identify genes with spatial expression patterns;
(2) to incorporate reference single cell RNA sequencing data along with spatial correlation structure in spatial
transcriptomics to enable accurate deconvolution of cell types on the tissue; and (3) to perform tissue
segmentation and detect tissue regions and microenvironment in a de novo fashion. In this proposal to
administrative supplements for equipment, we propose to use a single unit of GPU node to provide the
necessary GPU computation support for this project, solve the computational bottle neck created by the
increasingly large spatially resolved transcriptomics studies, and enhance the usability and applicability of the
proposed statistical methods and computational tools and hence their impact in this emerging research field of
spatially resolved transcriptomics studies. The proposed administrative supplement will ensure the successful
development of the proposed statistical methods and computational tools in the parent award and the high
impact of the developed methods to the scientific community.

Public health relevance
Project Narrative This application to the Administrative Supplements of Equipment proposes to provide essential computational support for the development of the proposed statistical methods and computational tools in the parent award. Such support is key to developing methods and tools to accommodate the increasingly large and complex spatially resolved transcriptomics data that are being collected today. The success of the project will ensure the success and the long-lasting high impact of the statistical methods and computational tools developed in the parent award.